Advanced wireless optogenetics and photometry system for neuroscience research

Project Summary/Abstract
Neuroscience research over the last decade has been revolutionized by many technological advancements.
Optogenetics and fluorescence imaging represent two distinct, and sometimes complementary tools used in
neuroscience research to study the central and peripheral nervous systems in the context of the BRAIN initiative.
Advanced interrogations of underlying neural circuits and biology are often frustrated, however, by technological
limitations that prevent the use of these approaches to study natural behaviors of untethered, freely moving
animals. Traditional fiber-optic cable for optogenetics and bulky metal cannulas connected with external
mechanical pumps for pharmacology impart significant damage to fragile neural tissue, limit the natural behavior
of freely moving animals, affect social interactions and movements in complex, naturalistic 3D environment, and
lead to persistent irritation at the biotic/abiotic interface due to mechanical mismatch and micromotions. These
drawbacks, together with the costly setup, of current technologies motivate the development of innovative
engineering designs to improve fidelity, operational ease, versatility and range of advanced brain research
studies with live animal models.
Our work during Phase II developed capabilities to build our existing system-level hardware and software, as
well as scalable manufacturing scheme to fabricate our wireless, battery-free optogenetics devices. Through
these efforts, NeuroLux has already achieved substantial success in disseminating tools for neuroscience
research, increasing user base to 80 laboratories in 11 countries in the last three years. The proposed work for
Phase IIB focuses on further propelling our initial success by refining critical aspects of our hardware, as well as
expanding our capabilities to include fully implantable, wireless, battery-free fluorescence imaging to monitor
neural activity in real time, in a manner that leverages our current hardware and software. Specifically, the
proposed work will (1) develop hardware for multi-enclosure operation with advanced features, (2) advance long-
range optogenetic stimulators with active, programmable control over illumination intensity, and (3) develop
optoelectronic photometers with options with integrated optogenetic stimulation capabilities.

Public health relevance
Project Narrative The goals of this project are to advance NeuroLux core technologies for wireless, battery-free light delivery for optogenetics and to expand our capabilities to include fully implantable, wireless, battery-free fluorescence imaging to monitor neural activity in real time, in a manner that leverages our existing system level hardware and software. Over the course of the project, we will refine the key aspects of our hardware and integrate advanced features driven by needs defined by our current customer base and the broader neuroscience community.